Manufacture of an intracerebroventricular Enzyme Replacement Therapy for CLN1 Batten Disease

Summary
The neuronal ceroid lipofuscinoses (NCLs) are a group of incurable neurodegenerative storage disorders
primarily affecting the brain and the retina of children and young adults, leading to dementia, blindness, epilepsy,
and early death, with a prevalence of approximately 1.5 to nine per million population (1.3 to 7 per 100,000 live
births). The infantile onset form CLN1 disease is caused by mutations in the CLN1/PPT1 gene, which codes for
the lysosomal enzyme palmitoyl-protein thioesterase-1 (PPT1) resulting in a reduction or absence of enzyme
activity. CLN1 disease usually presents between 6 and 24 months of age and there are 2-3 children with this
form identified each year and currently 24 known children with CLN1 in the US, 11 in Brazil and at least 10 in
the UK (with likely many more undiagnosed). There are currently no treatments available other than palliative
therapies and the disease is fatal. Human recombinant PPT1 (rhPPT1) expressed in CHO cells has been
previously reported to modify disease phenotypes following a single intrathecal (IT) and intravenous (IV)
administration in PPT1 deficient mice (Ppt1-/-). After successful completion of our Phase I SBIR in which we
exceeded our milestones monthly intracerebroventricular (ICV) administration of rhPPT1 produced statistically
significant treatment effects in Ppt1-/- mice, such as rescue of more than 60% PPT1 enzyme activity decreased
secondary enzyme levels, decreased the loss of neurons in all regions of brain and spinal cord and improved
gait and rotarod results. The CLN1 ERT data clearly pointed to ICV dosing as ideal for future studies, which is
also a preferred route according to physicians. Our Phase II SBIR has enabled us to 1. Prepare our quality
documents, 2 identify a CDMO (STC Biologics) who has manufactured our GLP quality protein for preIND toxicity
studies in rat. 3. Submitted a preIND request to the FDA (with the assistance of RTI International,). We now
propose in this project 1. production of GMP protein (with STC Biologics), 2. Continued development of quality
procedures, 3. Prepare a clinical trial protocol (with assistance from CTI Clinical Trial Services, Inc.), 4 and
submit an IND (with assistance from RTI). These collaborations will enable us to cost effectively and more rapidly
translate this potential treatment to the clinic that can potentially save the lives of children living with this
devastating disease. We have already obtained an Orphan Drug Designation and rare pediatric disease
designation from the FDA for rhPPT1 as a biological product for a “rare pediatric disease” which offers several
benefits in future upon FDA approval, including marketing exclusivity for 7 years and the potential to obtain a
rare pediatric disease voucher and thus provide a return on investment (current value ~$100 M). We are engaged
with CLN1 families and we are now well positioned to continue the development of this potential treatment for a
devastating disease. This proposed work would bring us closer to a clinical trial. Our work on developing rhPPT1
as an ERT for CLN1 would position us well to work on further rare diseases in future and grow CPI. There is an
important role to bring treatments to patients with ultra-rare diseases as illustrated by other much larger
companies such as Biomarin and Ultragenyx who we aspire to emulate.

Public health relevance
Narrative CLN1 disease (Infantile Neuronal Ceroid Lipofuscinosis, or Infantile Batten Disease) is characterized by progressive intellectual and motor deterioration, frequent seizures, loss of vision, and early death, caused by mutations in CLN1 gene, which codes for the lysosomal enzyme palmitoyl-protein thioesterase-1 (PPT1). Recombinant human PPT1 (rhPPT1) can be used as an enzyme replacement therapy for this ultra-rare disease and will ultimately improve the lives of children and families living with this devastating life-long disease for which there is currently no treatment. In our Phase I SBIR we have demonstrated statistically significant in vivo efficacy of rhPPT1 in mice and sheep, In our Phase II SBIR we have already submitted our preIND with a meeting scheduled for May 2023 and are currently generating GLP protein followed by IND-enabling toxicology studies. In preparation for a future clinical trial, we now propose 1. Production of GMP protein, 2. continue our quality documentation 3. prepare a clinical trial protocol and 4. submit an IND. The financial return on investment for this treatment is the FDA rare pediatric disease priority review voucher currently valued at ~$100M.